Laboratory Flexible Funding Model (LFFM) 2025

PROJECT SUMMARY (OVERALL):
The Michigan Department of Agriculture and Rural Development (MDARD) intends use this
opportunity to support activities to meet regulatory requirements, and improve its efficacy,
accuracy, and defensibility on a continuous basis and to maintain and enhance our current level of
services with our federal, state, and local partners.
This funding opportunity allows for the risk-based development of metrics, allowing MDARD to
better forecast emerging issues and hazards. This allow MDARD to work with our regulatory
partners to develop plans and processes to facilitate the increase sample volumes across our
human and animal food microbiology and chemistry sections, to increase the types of analysis,
and allow for new advanced technologies and methodologies to be explored within such fields as
Whole Genome Sequencing, allergens, food adulteration, enteric pathogens, toxic elements, and
economic fraud. The lab will maintain its ISO 17025 accreditation providing confidence and
defensibility in the lab's results. MDARD will continue to work with the Emergency Rapids
Response Team and the MDARD Food and Dairy Division and FDA to build a more robust and
effective food defense program.
The Michigan Department of Agriculture and Rural Development (MDARD) Chemistry Laboratory
intends to continue its basic scope which of testing for human and animal food; mycotoxins,
veterinary drugs, nutrient and heavy metals, crude fat content, crude fiber content, and protein
(Nitrogen) content, acid detergent fiber, neutral detergent fiber, filth, fish speciation, histamine,
cannabidiol potency in food products and foreign materials in feed products whilst increasing
sample volumes and participating in any food defense outbreaks, investigations, exercises, and
trainings.
The Michigan Department of Agriculture and Rural Development (MDARD) Microbiology Laboratory
emphasizes food safety for human food through surveillance testing for foodborne pathogens.
Testing is performed using validated and verified test methods. The lab routinely tests samples for
Salmonella, Listeria monocytogenes and pathogenic E. coli (Shiga-toxin producing E. coli, or STEC)
Surveillance manufactured food samples and fresh produce samples are tested for the presence
of the foodborne pathogens. Samples found to be contaminated with foodborne pathogens will be
reported to the Regulatory Division and FDA for possible regulatory action.

Public health relevance
Project Narrative (Overall) The Michigan Department of Agriculture and Rural Development (MDARD) intends to use this funding opportunity to support activities to meet regulatory requirements, and improve the laboratory's overall efficacy, accuracy, and defensibility on a continuous basis and to maintain and enhance our current level of services with MDARD's federal, state, and local partners. It allows for the risk-based development of performance metrics to base MDARD's laboratory division future objectives upon, allowing MDARD to better forecast and prepare for potential emerging issues and hazard. This award will allow MDARD to work with our regulatory partners to develop plans and processes to facilitate the increase sample volumes across our human and animal food microbiology and chemistry sections, to work with our regulatory partners in the process of increasing the types of analysis, and allow for new advanced technologies and methodologies to be explored such as Whole Genome Sequencing, allergens, food adulteration, toxic elements, and economic fraud. The lab will maintain its ISO 17025 accreditation providing confidence and defensibility in the lab's results. MDARD will continue to work with the Emergency Rapids Response Team and the MDARD Food and Dairy and Animal Feed Safety Divisions and FDA to build a more robust and effective food defense program.